Structural basis for chemosensation by insect olfactory ionotropic receptors

Project Abstract/Summary
Insects are guided by their chemosensory systems of smell and tase. A multitude of behaviors, such
as foraging, mating, navigation, and oviposition rely on smell and taste. For disease vectors such as
mosquitoes, their chemosensory systems guide host-seeking (attraction to humans) and biting. As
such, the chemosensory systems of insects are excellent targets for behavioral control, and
strategies that target insect smell and taste could have significant and widespread benefits from
reducing mosquito biting to preventing crop destruction by invasive pests. The chemosensory
systems of insects rely on the expression of 3 different receptor family members: the Odorant
Receptors (ORs), the chemosensory Ionotropic Receptors (IRs) and the Gustatory Receptors (GRs).
Of these three, IRs represent one of the most ancient and abundant chemosensory receptors on the
planet. IRs likely diverged ~600 million years ago from an ancestral ionotropic glutamate receptor
(iGluRs) to take on new roles as a multi-functional chemosensory receptor family. Chemosensory
insect IRs are a complex between an IR co-receptor and a ‘tuning’ IR that binds to a chemical ligand.
The IR co-receptors Ir8a and Ir25a share protein homology to iGluRs which contain a large amino-
terminal domain. In contrast, the tuning IRs lack this domain. The structure of mammalian iGluR
complexes has been solved by the Twomey group using cryo-EM. The structure of chemosensory
IRs remains unknown. A key limitation has been harvesting functional chemosensory IR-complexes
for cryo-EM analyses. The expression of IR complexes in cell culture systems does not lead to
functional complexes, likely reflecting defects in IR complex formation or cellular trafficking. To
address these limitations, we assembled a team of insect sensory biologists and structural
biologists. Using transgenic Drosophila that express an N-terminal tagged functional Ir8a co-
receptor (EGFP:Ir8a), we will: Specific Aim 1, develop methods to harvest functional Ir8a
receptor complexes directly from ~10,000,000 Drosophila antenna, and Specific Aim 2, purify
EGFP:Ir8a complexes from Drosophila tissues using nanobodies to EGFP followed by cryo-EM
analyses on the complexes as previously done for iGluR complexes. These experiments have the
potential to establish Drosophila as a viable in vivo tissue source for chemosensory receptor
purification. This work will also reveal the cryo-EM structure of chemosensory IRs, their
stoichiometry, and provide clues as to how this receptor complex evolved from iGluRs to be gated
by a variety of chemicals. This could lead to innovative new strategies to target these receptor
complexes to control insect behaviors.

Public health relevance
Narrative Insect receptors on sensory neurons that detect chemicals are critical for guiding insect behaviors. For example, mosquitoes use specialized smell receptors that detect human- derived acidic odors. A better understanding of the 3D structure of these receptors could lead to improved strategies to control the behaviors of insect pests.